Universal Anti-PAMP Agent to Improve Wound Healing

Innate immunity has considerable specificity and can discriminate between individual species of
microbes. In this regard, pathogens are “seen” as dangerous to the host and elicit an inflammatory response
capable of destroying the microbes. This immune discrimination is achieved through the recognition of microbe-
specific molecules (e.g., lipopolysaccharide, lipoteichoic acid, and peptidoglycan) by toll-like receptors on host
cells. Lipopolysaccharide, lipoteichoic acid, and peptidoglycan arising from dangerous bacteria are known as
Pathogen-Associated Molecular Pattern (PAMP) molecules. PAMPs impede wound healing by lengthening the
inflammatory phase of healing and contributing to the development of chronic wounds. Preventing PAMPs from
triggering the release of inflammatory cytokines will restore the optimal inflammatory response. However,
successful drugs are elusive because PAMPs originate from many different species of Gram-negative and Gram-
positive bacteria. Therefore, the need exists for a universal broad-spectrum therapeutic against LPS, LTA, and
PGN bacterial PAMPs.
The objective of this project is to investigate PEG-BPEI structure-activity relationships. The central
hypothesis is that increasing the steric bulk of PEG-BPEI reduces its ability to bind with PAMPs from S. aureus,
P. aeruginosa, E. coli, and K. pneumoniae and thus is unable to interfere with PAMP recognition by PRRs. We
will test our central hypothesis with the following specific aims: Aim 1: Correlate PEG-BPEI steric effects with
PAMP binding; Aim 2: Discover how PAMP + PEG-BPEI combinations reduce PRR activation. Data arising from
these aims will be significant because they are expected to provide strong scientific justification for the continued
development of anti-inflammatory agents applied to acute and chronic wounds. This project has added
significance because the data will be used to evaluate the strategy of using this agent to bind bacterial PAMPs
and prevent cytokine release; a strategy that enables other subsequent research and thinking. The proposed
work is innovative because we fill the technological gap with multi-purpose agents that disable PAMPs, dissolve
biofilms, and overcome antibiotic resistance mechanisms, making them superior to existing technology. The
rationale is that the agent will improve wound healing by counteracting LPS, LTA, and PGN bacterial products
that cause inflammation. Determining the ability to inhibit inflammatory cytokine release is necessary to evaluate
the therapeutic opportunities of the chemical molecules. We envision our discoveries as topical agents applied
to acute and chronic wounds because, in addition to the active moiety of the agent preventing cytokine release,
it also disables antibiotic resistance mechanisms and disrupts the biofilm matrix. This versatility of this agent
suggests that it may be an ideal therapeutic agent for use in the hundreds of millions of non-chronic skin or soft-
tissue infections (SSTIs), and the 4.5 million chronic wound infections, that occur each year.

Public health relevance
Project Narrative The proposed research is relevant to human health because wounds are infected with bacteria that leave behind debris when the bacteria are killed. This debris continues to cause inflammation and delays wound healing, leading to millions of chronic wound infections. The project seeks to understand how to disable this bacterial debris and speed wound healing, relevant to NIH’s mission by generating knowledge that can be used to develop new approaches to improve human health.